Mentoring Patient-Oriented Pharmacoepidemiologic Research in Rheumatic Diseases

PROJECT SUMMARY
Rheumatoid arthritis (RA) is a chronic inflammatory arthritis for which there is no known cure. However, with
medical breakthroughs in the past few decades, a dozen different biologic and targeted synthetic (ts) disease-
modifying antirheumatic drugs (DMARDs) directed toward specific components of the immune system are
currently available for patients with moderate-to-severe RA. While all these biologic and ts-DMARDs are highly
effective in controlling inflammation in RA, these agents carry a wide range of safety concerns including infections,
cardiovascular disease, thrombosis, heart failure, lower intestinal perforations, and malignancies. Given the
significantly expanded armamentarium for RA and increasing emphasis on treating to target to achieve remission
or low RA disease activity, it is important for both clinicians and patients to understand the data regarding drug
effectiveness and safety. However, there is a knowledge gap in concerning how one can compare directly across
these different DMARDs with regard to their benefits and risks in the absence of clinical trials. Moreover, few
studies have quantitatively assessed and incorporated patient preferences into weighing benefits vs. harms of
these drugs. The applicant, therefore, proposes a 5-year K24 award project with three specific research aims
which will: 1) emulate a target trial to evaluate head-to-head comparative effectiveness and safety of biologic
and ts-DMARDs in patients with RA using real-world data; 2) identify important predictors of safety events
associated with use of biologic or ts-DMARDs; and 3) conduct a patient-centered benefit-risk assessment of
these drugs incorporating patients’ relative treatment preferences. In addition, the applicant aims to grow and
strengthen a research training program in pharmacoepidemiology and patient-oriented outcome research in
rheumatic diseases. The applicant, Dr. Seoyoung C. Kim, is a rheumatologist and a doctoral trained
pharmacoepidemiologist. She has served as primary or secondary research mentor for over 30 pre- and post-
doctoral research trainees in the past decade. The applicant’s many ongoing research projects for
pharmacoepidemiologic and patient-oriented research, high degree of commitment to mentoring, and the
exceptional institutional resources will provide an outstanding environment for the development of junior
investigators. Furthermore, the applicant has assembled a strong team of highly qualified collaborators who can
serve as co-mentors for her trainees, and she will continue to refine her mentoring program and skills using
trainee feedback during the award period. This K24 award study will help generate real-world evidence-based
recommendations for the management of RA with biologic and ts-DMARDs, incorporating patients’ treatment
preferences and support the applicant’s ability to build a strong clinical research platform to mentor the next
generation of clinical researchers in pharmacoepidemiology and patient-oriented research in rheumatology and
promote their successful transition to independence.

Public health relevance
PROJECT NARRATIVE Rheumatoid arthritis is a chronic inflammatory arthritis, affecting 1% of the population worldwide. This mid-career investigator award project aims to provide much needed high-quality real-world evidence on comparative effectiveness and safety of currently available biologic and targeted synthetic DMARDs for rheumatoid arthritis, incorporating patients’ preferences. Furthermore, this award will allow the applicant to continue and expand her research training program in pharmacoepidemiology and patient-oriented outcome research in rheumatic diseases, preparing clinical investigators-in-training to make important research contributions.